Evident SLIDEVIEW VS200 Slide Scanner

PROJECT SUMMARY/ABSTRACT
Located in New York’s capital city, the University at Albany (UA) was established in 1844 as the first public
institution of higher learning in New York State. Today, this is the premier public research university in the Capital
District region, offering more than 17,000 students the opportunities of a large university while maintaining an
environment designed to foster individual success. This is achieved by promoting multidisciplinary and
collaborative research by undergraduate and graduate students, post-doctoral fellows, research staff, and faculty
affiliated not only with UA, but also with neighboring institutions like Albany Medical Center (AMC), the Neural
Stem Cell Institute (NSCI), and Rensselaer Polytechnic Institute (RPI). Recently, UA launched two major
initiatives. The Next Generation Artificial Intelligence (AI) Supercomputer Cluster for Education and Research at
UA aims to transform the AI supercomputing resources available in the Capital District. The Healthy Aging
Initiative aims to build an inter-institutional, interdisciplinary research, collaboration, and community-engaged
network focused on advancing knowledge about aging and translating that new knowledge into practice,
education, and workforce development. To expand our AI resources in STEM, while also celebrating our faculty’s
historic interdisciplinary collaborative research, we identified an urgent need for an Evident SLIDEVIEW VS200
research slide scanner. This advanced microscope is capable of automating image acquisition using up to five
different observation methods (Brightfield, Phase contrast, Darkfield, Polarization, Fluorescence). Its exquisite
robotics design allows to load and unload up to 35 sample trays with a maximum capacity of 210 slides rapidly
and safely, allowing the system to be versatile for users with different samples and image acquisition
requirements. The settings for image acquisition can be saved and shared among multiple uses, allowing “walk
away” slide scanning, which allows multiple users to plan for their image acquisition without the need of being
physically present in front of the microscope. To the best of our knowledge, this will be the first slide scanner
available for shared use in the Capital District. Therefore, the acquisition of this advanced imaging platform,
which will be accessible to users across different institutions, will be critical to streamline the workflow for a wide
variety of research programs across our major and minor user groups, encompassing diverse fields including
cellular neuroscience, cell and stem cell biology, cell-cell communication in organ development, microbial
communities in human health in the broader research community of New York’s Capital region. The modular
design of this instrument also offers excellent upgrade capabilities, making it ideally suited to meet the scientific
needs of cutting edge research programs in our region.

Public health relevance
PROJECT NARRATIVE The ability to quickly detect the spatial distribution of different biological markers across many cell and tissue samples is critical to understand how different molecular and cellular processes ultimately lead to human disease. The acquisition of the Evident SLIDEVIEW VS200 slide scanner, and its capacity for automated image acquisition using different imaging modalities, will transform multiple research programs that span a diverse range of fields including cellular and systems neuroscience, neurodegenerative diseases, organ and tissue development, drug discovery, cell-cell communication, delivery of targeted anti-cancer drugs, and microbiome spatial assembly.